Regulation of myeloid cell function by a novel putative lncRNA

PROJECT SUMMARY/ABSTRACT
Understanding the mechanisms that underlie the function and regulation of immune cells in health and disease
is critical to developing therapies aimed at modulating their function. Innate immune cells such as macrophages
represent a critical arm of the immune system. These cells not only represent the front line of defense against
microbes, but also mediate critical effector functions at the direction of the adaptive immune system.
Dysregulation of such effector functions can lead to pathogenic inflammation and tissue damage, as seen in
septic shock, an acute condition that results in the death in one out of three affected patients. Thus,
understanding the functional regulation of these cells can help to develop therapeutic interventions for such
diseases. Classical protein coding genes represent the minority of genetic elements in the eukaryotic genome,
and yet these genes have been the focus of the vast majority of functional studies to date, including those
investigating innate immune cell function. Surprisingly, the number of such genes does not increase with
organismal complexity, while the number of so-called non-coding genes does. This suggests that the latter genes
execute complex cell type-specific regulator functions. A class of such genes, called long non-coding RNAs
(lncRNAs) have recently emerged as critical regulators of immune cell function. We have identified such a
lncRNA, called U90926, as almost exclusively expressed in activated myeloid cells. The function of this gene is
unknown. We have generated mice deficient in this gene, and we propose an experimental plan to functionally
dissect the role of this gene in myeloid cell effector function, both in vitro and in vivo, in clinically relevant models
of human inflammatory disease.

Public health relevance
PROJECT NARRATIVE Despite their abundance, the specific functions of most lncRNAs in health and disease remain unknown. We propose to characterize the function of a novel, activated myeloid cell-specific lncRNA called U90926 in in vivo and in vitro models of inflammation, and preclinical models of septic shock, an acute condition that results in the death in one out of three affected patients.